Mechanisms of balancing the immune response during cryptococcal meningoencephalitis

Project Summary
Cryptococcosis is an opportunistic fungal infection that is caused by Cryptococcus neoformans and
often occurs in immunocompromised individuals including HIV/AIDS patients. Although the infection starts in
the lung via inhalation of the pathogenic fungus, the most common manifestation of cryptococcosis is
meningoencephalitis, which is a leading cause of mortality of HIV/AIDS patients and accounts for proximately
181,000 deaths worldwide annually. The high susceptibility of HIV/AIDS patients to C. neoformans infection is
attributed to their impaired cellular immunity. Consequently, C. neoformans proliferates in the brain without
control, leading to microbe-mediated brain damage. Antiretroviral therapy (ART) is a major advance in treating
HIV/AIDS patients by restoring cellular immune responses. However, after initiation of ART, up to 30% of
HIV/AIDS patients with cryptococcosis develop immune reconstitution inflammatory syndrome (IRIS), an
aberrant excessive immune response leading to host-mediated brain damage. Furthermore, post-infectious
inflammatory response syndrome (PIIRS) occurs frequently in HIV-negative patients with cryptococcal
meningoencephalitis. Therefore, a robust immune response is required for controlling the fungal growth;
however, the immune response must be tightly controlled to avoid host-mediated brain damage during
cryptococcal meningoencephalitis. A critical gap in our understanding remains: what are the mechanisms of
maintaining the balance between protective immune responses and immunopathology during cryptococcal
meningoencephalitis-associated IRIS? IL-10 is an important cytokine with anti-inflammatory properties and its
production was enhanced in the cerebrospinal fluid of HIV/AIDS patients during cryptococcal IRIS. Based on
clinical data and our preliminary murine studies, we hypothesize that IL-10 is critically involved in balancing the
immune responses during cryptococcal meningoencephalitis-associated IRIS. We will test the hypothesis in a
murine model that closely mimics cryptococcal IRIS of HIV/AIDS patients, by addressing the following aims: (1)
To determine the mechanism(s) involved in regulation of the immune responses by IL-10 during cryptococcal
meningoencephalitis-associated IRIS; (2) To determine the mechanism(s) involved in induction of IL-10 in the
brain during cryptococcal meningoencephalitis-associated IRIS. If successful, the findings from this study
would be fundamental for understanding regulation of immune balance during cryptococcal
meningoencephalitis-associated IRIS and provide scientific basis for targeting this cytokine aiming at
controlling deleterious inflammation in the brain of cryptococcal IRIS/AIDS patients.

Public health relevance
Project Narrative Cryptococcus neoformans is a pathogenic fungus that causes fatal meningoencephalitis in immunocompromised individuals including HIV/AIDS patients worldwide. In this project, mechanisms involved in regulating cryptococcal IRIS will be studied using a murine model that reproduces key aspects of cryptococcal IRIS of HIV/AIDS patients. Understanding the mechanisms involving in regulating cryptococcal IRIS of HIV/AIDS patients is fundamental for developing therapeutic strategy for this disease.